Administrative Core A

PROJECT SUMMARY – ADMINISTRATIVE CORE A
Administrative Core A will be responsible for managing, coordinating, and overseeing the entire range of the
Texas D-CFAR activities, monitoring progress, and ensuring that the project milestones are met and within the
proposed timelines. This responsibility includes comprehensive oversight of all Texas Developmental Center
for AIDS Research (D-CFAR) activities at the three primary institutions: Baylor College of Medicine (Baylor)
and University of Texas Health Science Center at Houston (UTHealth), both in Houston's Texas Medical
Center, and the Texas Biomedical Research Institute (TxBiomed) in San Antonio. The Texas D-CFAR will
focus its research over the next five years on the theme: “Ending HIV and Optimizing HIV Health in Texas.”
Core A will oversee efforts to realize the goal of the Texas D-CFAR, to significantly advance HIV research in
Texas, by focusing on the Texas D-CFAR's mission to promote HIV research at the institutions by facilitating
collaboration in HIV research, offering pilot funding to all early stage investigators and to established
investigators not currently involved in HIV research, and offering core services to HIV researchers.
Administrative Core A will integrate exceptional basic, translational, clinical, health services and public health
research to train the next generation of HIV scientists and engage the community. Core A has led the
performance of a comprehensive gaps and needs analysis and will organize efforts to meet those needs and
fill those gaps. To achieve its goals, Core A has established the following two Specific Aims: 1) Organize
activities and programs that strengthen the Texas D-CFAR research environment; and 2) Provide strategic and
financial management for the Texas D-CFAR. Administrative Core A will execute decisions of the Executive
Council; develop and implement the annual strategic plan; provide leadership and guidance for new initiatives;
organize the External Advisory Board, Internal Advisory Board, and Community Advisory Board; manage
Texas D-CFAR finances and personnel; and interact with institutional leadership. Administrative Core A will
provide logistical and other support to the other Cores and the Substance Use Scientific Work Group, assist
with recruitment of new faculty, facilitate communication and information dissemination, coordinate enrichment
activities such as research and education presentations, hold an annual Texas D-CFAR Conference.
Administrative Core A will maintain records and prepare reports, including the annual Texas D-CFAR progress
report and continuation application; and communicate with NIH program officers. The Administrative Core will
be based at Baylor College of Medicine and will coordinate administrative matters with UTHealth and
TxBiomed. Ultimately, Administrative Core A will provide the administrative support and infrastructure to
support successful advancements in HIV research of the researchers leading to progression to a full CFAR
application and impact on efforts to end HIV and improve health for people with HIV in Texas and beyond.
These efforts will lead to a full CFAR application in 5 years.